Dysregulation of Endometrial Invasibility Proximal to Uterine Scar as a Mechanism of Placenta Accreta

Abstract
Placenta accreta is a serious maternal condition affecting more than 1 in 300 women in the US, and rapidly
increasing in frequency. Accreta is characterized by the placenta invading too deeply into the uterus,
necessitating hysterectomy upon parturition. The major correlate of accreta (or increta, or percreta) is the
presence of previous uterine scar, mostly due to caesarian surgery, although the disease could manifest without
previous scars. Very little is understood about the cellular and molecular mechanisms underlying this disease,
leaving limited therapeutic avenues to pursue. Our overall hypothesis states that while normal placental
invasion is predicated on a fine balance of pro- and anti-invasable signaling at the maternal-fetal interface,
placenta accreta is a response of scar induced dysregulation in this signaling, leading to excessive and un-
controlled invasion. Specifically, we posit that the dysregulated biomechanical microenvironment at the scar
transforms decidual fibroblasts into an inflammatory state, producing chemoattractive cytokines recruiting
extravillous trophoblasts towards the scar. We have developed a framework termed ELI (Evolved Levels of
Invasability) that explains the highly invasive nature of placentation in certain mammals as primarily a stromal
characteristic. Based on ELI framework, and our preliminary findings, we posit that aberrant matrix cues from
scar dysregulate decidual defense, resulting in uncontrolled trophoblast invasion leading to accreta. Using a
bioengineered model of scar decidua (high rigidity, high collagen density, anisotropic nanotopography), we
observed dysregulated mechanoresponsive signaling in decidual fibroblasts (dESFs), resulting in chemotactic
recruitment of extravillous trophoblasts (EVTs) towards scar, as well as promoting EVT invasion by altered dESF
contractility. Specifically, scar results in high activation of Protein Kinase C by Piezo-1 mechanosensitive Ca2+
channel. Increased PKC activation phosphorylates NFkB, a master regulator of inflammatory response, resulting
in production of IL-8 and G-CSF, potent chemoattractants for EVTs. In this proposal, we will elucidate the
missing links in these mechanisms using a combination of spatially defined exploration at transcriptional,
molecular and tissue level scales. We have developed many technological platforms specifically for
understanding stromal invasion of trophoblasts: a model of scar decidua that recapitulates accreta phenotype, a
nano-fabricated platform for quantification of stromal invasion, cellular force measurement at EVT-dESF
interface, and a microfluidic platform to measure paracrine cross-talk between EVTs and dESFs. As accreta is a
spatially defined pathology, we will use spatial transcriptomics in human accreta samples to identify changes
in decidual state proximal to scar. Finally, we will profile, and establish the causality of paracrine cross-talk
between dESFs and EVTs in accreta manifestation. This integrated study combining systems and mechanistic
approaches will shed light to elucidate the biology of scar induced uncontrolled placental invasion, and identify
targets to therapeutically limit accreta pathogenesis.

Public health relevance
Narrative Placenta accreta is a serious disease with dysregulated placental invasion, molecular mechanisms of which are poorly understood. We propose an integrated study of accreta elucidating key components associated with scar induced placenta accreta and possible diagnostic and targetable mechanisms of this highly invasive condition.